The role of TGF beta pathway dysregulation in pathogenesis of collagen VI-related muscular dystrophy

Project Summary/Abstract:

Mutations in collagen VI cause a spectrum of muscle disease ranging from severe Ullrich congenital muscular
dystrophy to the milder Bethlem myopathy. The three protein components of collagen VI encoded by COL6A1,
COL6A2, and COL6A3, undergo extensive assembly after translation before being excreted and incorporated
into the extracellular matrix (ECM). Collagen VI is an integral component of the ECM, making collagen VI
related dystrophies prototypical disorders of the muscle ECM. However, how these mutations result in muscle
weakness, atrophy, degeneration and fibrosis remains unknown and no specific therapies are available that
can alter the natural history of this disease. In this study, we propose to characterize the histologic and
functional changes in skeletal muscle of a new mouse model of collagen VI related dystrophies with
homozygous deletion of the Col6a2 alleles, paying special attention to dysregulation of growth factor pathways
associated with these changes. For the interventional phase of this study, we propose to test effectiveness of
medications in treating the manifestation of disease in this animal model. This study will also provide funding
for in depth training of an early career clinician scientist with prior neuromuscular medicine training to develop
laboratory techniques and scientific skills to conduct translational research and pre-­clinical studies of animal
models of muscular dystrophies.

Public health relevance
Project Narrative The proposed research project studies how mutations in a collagen gene, collagen VI, cause muscle weakness and disability. In addition, it proposes to test candidate drugs to see if they can change the disease course in a mouse model of this disease.